Spreading Tau Pathology in Non-Amnestic Alzheimer's Disease

PROJECT ABSTRACT
Neurofibrillary tau is consistently linked to neurodegeneration and cognitive decline in Alzheimer’s disease
(AD) over a range of clinical presentations and anatomical phenotypes, including patients with primary
impairment in memory, visuospatial, language, and somatomotor domains. One model of tau progression that
has attracted recent attention involves region-to-region transport of pathologic tau along axonal white matter
(WM) connections; however, evidence for axonal transport in murine models may not translate to the complex
biology of AD in humans. One potential test of the axonal transport hypothesis is whether changes in WM
connections predict disease progression between tau-positive and tau-negative regions. If axonal transport is a
common mechanism of tau spread, it should leave signature WM changes consistent with a patient’s
anatomical and clinical phenotype. However, WM changes are underinvestigated in non-amnestic mild
cognitive impairment (MCI) and AD and rarely studied in the context of longitudinal tau changes. Moreover,
imaging markers of WM change may reflect features of the AD pathologic process or co-occurring
cerebrovascular disease. We propose a multimodal clinical, imaging, and pathologic investigation to test the
hypothesis that WM changes predict region-to-region tau spread independent of CVD. Aim 1 will combine
longitudinal positron emission tomography (PET) imaging of tau progression with 3-Tesla MR imaging of WM
changes using diffusion MRI to assess evidence that WM changes mediate tau spread in a syndrome-specific
manner. The axonal transport model predicts that longitudinal changes in diffusion MRI will mediate region-to-
region tau PET progression in syndrome-specific brain networks. Aim 2 will use high-resolution 7-Tesla MRI of
CVD-related brain changes, including WM hyperintensities and microbleeds, to quantify vascular disease
burden across amnestic and non-amnestic AD and to assess CVD co-pathology as a potential confound that
would explain WM changes in AD. Based on preliminary data, we hypothesize that all clinical variants of AD
will exhibit age-related CVD including WM hyperintensities and microbleeds but will not fully explain tau-related
WM changes. Finally, Aim 3 will provide postmortem validation of imaging findings and advance digital
pathologic methods to quantify AD- and CVD-related pathology in amnestic and non-amnestic AD. In this aim,
the axonal transport model predicts that longitudinal change in grey matter tau will be mediated by tau
deposition and degeneration in connecting WM tracts, but not by CVD pathologic burden. By comparing
heterogeneous phenotypes and cognitive networks, we seek to demonstrate that WM-mediated tau spread is a
generalizable mechanism of disease progression across cognitive subtypes of MCI/AD and is independent of
CVD-related changes. This research will contribute to multiple milestones in AD and related dementias (ADRD)
by investigating relationships between tau, CVD, and WM change (Milestones 2.L and 2.S); and developing
non-invasive markers for longitudinal tracking of CVD-related brain changes (Milestone 9.R).

Public health relevance
PROJECT NARRATIVE One influential theory of how Alzheimer’s disease spreads in the brain is that toxic tau is transported through the brain’s white matter, along the axons of neurons; however, evidence for this model is incomplete. If axonal transport is a common mechanism of tau spread, it should leave behind a signature of tau accumulation and degeneration affecting the white matter networks that correspond to a patient’s primary cognitive symptoms. We will combine longitudinal imaging of tau progression and white matter change with postmortem histopathology to assess evidence for the axonal transport model in amnestic and non-amnestic variants of Alzheimer’s disease that are known to affect distinct cognitive networks.